Orexins and severity of menopausal symptoms in mice

PROJECT SUMMARY/ABSTRACT
In the United States, over a million women experience menopause each year. Women
experience many physiological changes through their menopausal transition that often include
severe sleep disturbances, anxiety, and hot flashes. Up to 60% of menopausal women have
sleep disturbances that impact their daily life. In addition, they have higher rates of anxiety and
longer lasting responses to stressful events. Though these menopausal problems impact the
lives of women in many ways, the underlying neuronal mechanisms are largely unknown. Long-
term hormone replacement therapies carry health risks. Identifying the neuronal mechanisms
that drive these symptoms will provide additional therapeutic opportunities, with potentially fewer
side effects. Hypothalamic neurons that express the orexin neuropeptides may be a key site
influenced by the chronic low estradiol (E2) environment that leads to menopausal symptoms.
The orexin neurons promote high arousal and increased sympathetic tone. Post-menopausal
women have higher plasma levels of orexin, and rodents with E2 deficiency from ovariectomy
(OVX) have increased expression of the orexins which is normalized by E2 replacement.
Identifying the mechanisms through which low E2 disrupts sleep and stress systems is crucial
for improving the lives of menopausal women We hypothesize chronically low E2 results in high
orexin tone, and consequently, more frequent waking from sleep and increased time awake. As
the orexin neurons also regulate autonomic responses, we predict that this high orexin tone
increases the frequency of vasomotor responses (VMRs). Collectively, these multidisciplinary
experiments will improve our understanding of how the orexin system contributes to poor sleep
and VMR observed in a mouse model of menopause. From a translational perspective, these
experiments should enable more targeted treatment of menopause symptoms using
medications such as orexin antagonists.

Public health relevance
PROJECT NARRATIVE Women experience many physiological changes throughout the menopausal transition. This project uses genetically targeted neuroscience techniques in mice to test whether the orexin neurons of the lateral hypothalamus recruit known arousal-promoting and thermoregulatory neurons to increase the severity of menopausal symptoms of hot-flashes and sleep disruption.